Identifying HPV-host interactions using network-based analysis of preexisting transcriptomic data

Infections with human papillomaviruses (HPVs) are the most common sexually transmitted infection in the US.
In addition to causing cervical and other anogenital cancers and a rising incidence of head and neck cancer,
HPVs are responsible for an estimated 5% of cancers worldwide.
Importantly, persistent infection, and not an acute infection, is the primary risk factor for (cervical) cancer
development. Thus, understanding the virus-host interplay that promotes or restricts viral persistence has
important implications for HPV biology and human cancers.
Until recently, it has been challenging to study the immediate early events of the HPV lifecycle following
infection and how these events contribute to initial genome amplification during the establishment phase and
long-term viral persistence. We used a single-cell genomics approach to identify cellular factors involved in
viral infection and persistence.
The R01, this diversity supplement proposal is associated with, explores how protein arginine N-
methyltransferase 1 (PRMT1) regulates RBM15 controlled m6a deposition on viral mRNA to regulate
alternative splicing throughout viral infection temporally. Amy Banka recently joined my lab to reanalyze large
published genomics datasets using gene coexpression networks. Specifically, by comparing transcriptomes of
HPV(+) cells along the progression from early infection to cancer progression, we aim to identify coexpression
networks that will illuminate how HPV rewires these cells throughout the viral life cycle. This approach may
identify new druggable targets or identify biomarkers to inform clinical practice.

Public health relevance
The proposed work will provide insights into the interplay between prevalent cancer-causing human papillomaviruses (HPVs) and the host cell. From this work Amy Banka will analyze existing RNA Seq data of HPV(+) and HPV(-) human tumors to understand how HPV regulates establishment of infection and long-term persistence, the risk factor for HPV-associated cancers.